CHARACTERIZATION OF PATHOGENIC MURINE LEUKEMIA VIRUSES

This project is concerned with isolation and biological and molecular characterization of C-type murine leukemia viruses (MuLVs), with emphasis on the replication competent non- oncogene containing agents. A major objective is the delineation of the molecular genetics of MuLV-related pathogenesis in mice of leukemias and lymphomas, and non-neoplastic changes such as lymphoproliferation, immunosuppression, or neurologic disease. Attempts to identify viral genes which determine phenotypes such as type of disease use recombinant virus genomes constructed from molecular clones of viruses with differing properties. Mice of selected inbred strains are inoculated with virus preparations which represent biologically or molecularly cloned stocks of parental, recombinant, or site-specific mutant genomes. Replication of virus is measured and mice are examined for gross and microscopic pathology, and tumors may be examined by flow cytometry, for recovery of virus, or molecularly for host gene alterations such as new proviral integrations or gene rearrangements. Studies with Moloney and Friend MuLVs, which induce in NFS mice almost exclusively T-cell lymphoblastic lymphoma or erythroleukemia, respectively, have established that the major determinant of disease specificity lies within that portion of the LTR comprising direct repeat sequences identified with virus transcriptional enhancer signals, one element of the enhancer having a predominant effect. Chimeric genomes are also being tested in an attempt to clarify the mechanism of lymphoma induction by an unusual MCF virus, NS6 MCF. In a third system, the LP-BM5 lymphoproliferative and immunosuppression syndrome, isolation and characterization of the components of disease-inducing virus stocks are in progress.